Dietary fatty acids drive pancreatic cancer development

PROJECT SUMMARY/ABSTRACT
Despite significant advances in cancer care, pancreatic ductal adenocarcinoma (PDAC) remains the third leading
cause of cancer death in the United States with a 5-year survival rate of ~10%. Obesity and high fat diet (HFD)
consumption increase PDAC risk in human cohorts and accelerate PDAC progression in mice, but the
mechanistic basis for these relationships is not well understood. Given the rapid rise in both the worldwide
prevalence of obesity and consumption of dietary fat, deciphering mechanisms of obesity-driven PDAC could
broadly impact human health. The translational relevance of prior diet research, however, has been limited by
uncontrolled variations in fat source and intake across human populations and mouse experiments. Therefore,
whether and how specific dietary fats promote pancreatic tumorigenesis remain critical unanswered questions
of great societal importance. Leveraging a unique isocaloric panel of HFDs differing only in fat source, we
identified a correlation between consumption of diets high in oleic acid – a monounsaturated fatty acid typically
associated with good health – and enhanced tumor development in a genetic model of PDAC that faithfully
mimics the genetic and histologic progression of the human disease. We further observed that tumorigenesis
correlated with increased incorporation of oleic acid into specific phospholipids in tissues, including the pancreas.
In this proposal, we aim to test the hypothesis that excess dietary oleic acid directly incorporates into cellular
lipids in the pancreas to drive PDAC development. The studies in Aim 1 utilize sophisticated genetic,
pharmacologic, and dietary approaches to modulate systemic oleic acid levels and establish whether excess
oleic acid is necessary and sufficient to promote pancreatic tumorigenesis. The proposed work in Aim 2 uses
lipidomic analyses to clarify the relationship between dietary fatty acids and pancreatic lipid composition during
PDAC progression and tests whether specific resultant unsaturated lysophospholipids drive tumorigenesis.
Finally, the experiments in Aim 3 combine metabolic and radioactive isotope tracer analyses with conditional
knockout models to decipher the mechanisms by which dietary oleic acid is directly taken up by the pancreas
and whether inhibition of fatty acid uptake pathways in pancreatic cells blocks the pro-tumorigenic effects of oleic
acid. Together, these studies will link fatty acid consumption to specific changes in pancreatic lipid composition
as driving forces in PDAC progression. Results from this work have transformative potential to identify novel
targeted dietary and pharmacologic strategies for the prevention of a largely incurable cancer.

Public health relevance
PROJECT NARRATIVE Obesity and excessive fat consumption increase the risk of pancreatic cancer, but how they contribute to tumor development is not completely understood. In this proposal, we aim to determine how dietary fatty acids directly modulate pancreatic lipid composition to drive the formation of one of the most lethal and incurable cancers. Results from this study may lead to novel targeted dietary and pharmacologic strategies for the prevention of pancreatic cancer and possibly other obesity-driven cancers.